Development and testing of Carbon Quantum Dot architectures to arrest neurotoxicant-insult- related outcomes

Exposure to pesticides, fungicides and herbicides is linked to neuronal injury, neuronal loss and the onset and
progress of neurodegeneration. The parent R16 grant was based on preliminary data revealing that organo-acid-
derived Carbon Quantum Dots (CQDs) resolve pesticide-associated neuronal dyshomeostasis. These data
underscored the interference by CQDs in the soluble-to-toxic transformation of amyloidogenic proteins and their
ability to scavenge free radicals and mitigate reactive oxygen species stress, an outcome of their sp2-
hybridization-rich architectures. Since then, we have synthesized and characterized a number of other CQDs
derived from blood-brain barrier penetrating organic acids and metabolites (caffeic acid, quinic acid, chlorogenic
acid, and tyrosine) and established their ability to intervene experimentally, in vitro and in vivo in the trajectory
to pesticide-driven neurodegeneration. Nevertheless, we observe CQD-specific differences in i) their ability to
prevent fibril formation, ii) cytotoxicity iii) intracellular free radical scavenging ability iv) ability to rescue
dopaminergic neurons from paraquat-associated ablation and v) restituting pesticide-exposure-associated loss of
locomotion in nematodes. We hypothesize that a knowledge of the potential mechanism(s) by which CQDs
intervene against xenobiotic insult-associated neurotoxicity in vitro and in vivo will facilitate their
development, screening and transitioning to vertebrate models of pesticide-insult associated
neurodegeneration. To bridge the mechanistic knowledge-gap we propose to image the intrinsically fluorescent
CQDs in vitro and in vivo to determine their bioavailability, subcellular distribution and localization within
SHSY-5Y cells and in the C. elegans nervous system. In combination with GFP-tagged α-synuclein expressing
cells and transgenic worms (that express neurons and amyloid-forming proteins tagged with different colors), we
will observe and identify where CQDs localize and their mechanism of action when the cell (and worm) is exposed
to xenobiotic-insult. Outputs that will be quantitatively measured include (prevention of) amyloid-protein
aggregation, reduction in the levels of free radicals and prevention of neuronal ablation. Furthermore, the use of
confocal microscopy will allow us to examine pesticide-associated neurotoxicity, including neuronal
development, neuronal absence or shrinkage, absence of cell bodies, and reduction in the fluorescence intensity
and the effect of CQDs to overcome this toxicity. In conclusion, by examining and characterizing the nanoscale
behavior of cell lines, neurons and molecules within live tissue in the presence of CQDs, we will reduce barriers
in our understanding of the mechanistic role of CQDs in rescuing cell lines and organisms (C. elegans) from
pesticide-associated neuronal dyshomeostasis. The data from this proposal will pave the way for their testing in
vertebrate models of environmental toxicant-associated neurodegenerative outcomes. The proposed studies are
relevant to public health given the incidence of Parkinson’s and Alzheimer’s diseases associated with pesticide
exposure and are NIH mission-specific.

Public health relevance
While Carbon Quantum Dots (CQDs) generated from organic acids have been shown to intervene in pesticide- associated models of neurodegenerative onset, their mechanism of action has remained elusive. Here, we will determine in vitro and in vivo CQD subcellular distribution and localization and potential mechanism(s) of interventional action when cell-lines and nematodes are exposed to pesticide-insult. The proposed work is important because, if successful, it advances CQDs testing in vertebrate models of pesticide-associated neurodegenerative disorders.